Inferential methods to assess the incremental value of new biomarkers in risk classification models

Abstract This proposal aims to develop statistical methods to evaluate improvement in risk classification measures due to the inclusion of new biomarkers. Risk classification modeling has a direct impact on patient treatment and health. These models are used to identify the need for diagnostic testing in the general population, or the type of treatment to be administered in a specified patient population. The most common risk classification improvement measures include the difference in the area under the receiver operating characteristic curve, the net reclassification index, the integrated discrimination improvement, and the difference in sensitivity and specificity. The new statistical methods will provide a metric to decide whether a change in patient risk, stemming from the evaluation of new biomarkers, is random variation or a true improvement in the accuracy of a risk classification model. The metric is defined through asymptotic distribution theory within a nested models framework. Methods to assess improvement in the accuracy of risk models are not well-developed, with current methods relying on classical hypothesis tests of association. These tests may lead to dissonance, since the results of parametric association statistics may not align with the nonparametric risk improvement statistics used in the models being evaluated. The objective of this grant proposal is to develop a coherent statistical inferential strategy that directly measures the incremental value of new biomarkers in risk classification models with binary and survival endpoints. The aims of the proposal are: 1) To develop inferential methods for the difference in concordance probability measures from nested proportional hazards models with a survival endpoint.2) To develop inferential methods for the incremental value of Net Reclassification Index (NRI) and Integrated Discrimination Improvement (IDI) with binary and survival regression models. 3) To develop inferential methods for the incremental value of sensitivity and specificity with binary and survival regression models. Measures of risk classification improvement impact medical decision making. The statistical evaluation of the incremental benefit of a new panel of markers, in relation to clinical measures and laboratory tests that are acquired in the course of routine clinical practice, will play a role in the level of confidence physicians and medical researchers have in updating their medical intervention algorithm.

Public health relevance
Project Narrative Clinical predictors are used to assess the risk of a disease for an individual in the general population or the risk of death or non-response to treatment for a patient already diagnosed with an illness. Risk classification models are used to combine clinical predictors to create a risk score and to determine if new biomarkers add information to this risk score. The purpose of this research is to develop statistical methods that will provide a metric to decide whether a change in a patient's risk score, stemming from the evaluation of new biomarkers, is random variation or a true improvement in the accuracy of the risk classification model, and hence whether the new biomarkers should be included in the subject evaluation going forward.